INTELLIGENT WHEELCHAIR DESIGN

Independent mobility is crucial for childhood development and adult functional independence. We propose to develop a "smart wheelchair" to serve as (1) a mobility aid to provide safe and independent motion to users immediately and (2) an instructional tool to help users develop skills necessary to operate a power wheelchair without technological intervention. The smart wheelchair will make use of a variety of sensors attached to an on board computer to provide navigation assistance to the wheelchair operator. In Phase I, a prototype will be developed that accepts input from a standard analog joystick and shares control of the wheelchair with the user to prevent collisions with obstacles. The prototype will be evaluated by both clinicians and potential users during clinical trials. In Phase II, the prototype will be expanded to accommodate multiple input methods and provide varying levels of assistance to the wheelchair user depending on the user's needs and abilities. PROPOSED COMMERCIAL APPLICATIONS The Smart Wheelchair System has two commercial applications. As a mobility aid it will provide immediate mobility to individuals currently unable to operate a power wheelchair. As a training aid it will be used by therapists in assistive technology clinics and school systems active in wheeled mobility to help clients to safely develop the skills needed tn independently operate a standard power wheelchair. In the long term it will provide a foundation for future development in intelligent mobility assistance.